Structure and mechanism of how cells read and repair the genome

Research Summary
Our research focuses on two fundamental cellular processes: the regulation of gene expression through
transcription and the repair of DNA damage using the non-homologous end joining (NHEJ) pathway. We study
how cells initiate and regulate transcription, a process crucial for converting DNA information into RNA,
involving complex interactions between various proteins and the DNA itself. This includes the assembly of the
transcription machinery at gene promoters and the role of specific proteins that help navigate and modify the
surrounding chromatin, making genes accessible for transcription. We also explore how cells respond to DNA
damage, particularly double-strand breaks, which are among the most critical types of genetic damage. Our
work investigates the NHEJ pathway, which directly repairs these breaks by joining DNA ends. Understanding
this pathway is essential, as improper repair can lead to genomic instability and diseases, including cancer. By
employing advanced imaging and molecular techniques, we aim to elucidate the intricate mechanisms behind
these cellular functions. This research not only deepens our understanding of cellular biology but also has
implications for developing new therapeutic strategies for diseases related to gene expression errors and DNA
repair defects. Through this integrated approach, we seek to uncover how complex protein interactions govern
gene regulation and maintain genetic stability in cells.

Public health relevance
Project Narrative Our research explores the mechanisms of eukaryotic transcription regulation, focusing on the formation and regulation of the transcription initiation complex and the role of transcription elongation factors. We employ techniques like cryo-electron microscopy to understand the interaction between transcription machinery, chromatin remodelers, and histone modifications. Additionally, our studies extend to the dynamics of DNA repair, specifically through the non-homologous end joining pathway, highlighting its critical role in genomic stability and disease prevention.